Otolaryngology Clinician-Scientist Training Program

Project Summary/Abstract
Basic science, translational, and clinical research in Otolaryngology – Head and Neck Surgery is making
remarkable advances that affect the way we treat patients. A critical component of nourishing and expanding
such improvements in patient care is to facilitate the partnership of clinicians and basic scientists. One way to
achieve this is by training more clinician-scientists. Herein, we propose to implement an otolaryngology
research training program designed to cultivate clinician-scientists. Our Otolaryngology Clinician-Scientist
Training Program is designed to provide residents and medical students with intense research experiences, a
structured didactic program, and close mentorship and guidance in how to integrate clinical and research
activities. Trainees will be ingrained with the philosophy that research is intrinsic to an academic surgeon’s
career and that they should build their career by sustaining excellence in both research and clinical care. We
will heavily recruit trainees from underrepresented groups. If our training program is successful, our graduates
will become independent NIH-funded investigators in faculty positions in academic departments. The ultimate
long-term goal, of course, is for them to improve human health by advancing our field via scientific discovery
that is translated to clinical care.

Public health relevance
Project Narrative Basic science, translational, and clinical research in Otolaryngology – Head and Neck Surgery is making remarkable advances that affect the way we treat patients. Herein, we propose to implement a research training program designed to cultivate clinician-scientists. The ultimate long-term goal of this program is to train the next generation of clinician-scientists who will improve human health by combining scientific discovery with clinical care.